UCSF - UCB TRAC Developmental Core

PROJECT SUMMARY – Developmental Core
The UCSF-UCB TRAC Developmental Core will be the principal vehicle used to attract and support new
investigators (NIs) pursuing tuberculosis (TB) research and investigators wanting to enter the TB field through
an active mentoring program and innovative developmental pilot awards program. The Developmental Core will
support emerging scientific leaders in TB research via a platform of services to support a continuum of ideas to
independence in TB research, offering mentoring, professional development, proposal support, and research
funding. UCSF-UCB TRAC Developmental Core will support investigators by 1) offering a comprehensive
structured career development program for NIs that is TB-specific and includes sustained mentoring; 2) offering
peer-reviewed pilot awards to support innovative multidisciplinary research and help launch TB research science
careers; 3) develop a community of practice for TB researchers that fosters equitable international research
partnerships and mentoring in TB. These activities will be complemented with overarching development
principles linking across Cores, including: (a) focus on team-science and multidisciplinary research; (b)
commitment to diversity, equity, and inclusion, including addressing inequities that undermine TB science; and
(c) an expansive vision for who/how we should be engaged with TB research. Through training, mentoring, and
funding of awards, the Developmental Core will enhance and stimulate TB research conducted at UCSF, UCB,
and our affiliated international sites and will attract and support the next generation of TB researchers.